Vasculogenic Regenerative Medicine Technology

Modified Project Summary/Abstract Section
Vascular tissue engineering approaches based on endothelial cell conversion in vitro face the challenge of transplantation,
acceptance and integration into the recipient vascular system. Regenerative medicine approaches to achieve in vivo
vasculogenic reprograming may spare such challenges and must negotiate with the recipient site’s biological processes
during inducible vasculogenesis (iV). In 2017, we reported on iV of skin in vivo using a nanotechnology-based TNT (tissue
nanotransfection) bioengineering technology wherein three transcription factors EFF (TNTEFF) proved to be vasculogenic in
vivo. TNTEFF markedly increased vascularization of ischemic tissue and has been reproduced in subsequent publications.
We know that a state-change of skin fibroblasts to vasculogenic fibroblasts (VF) in vivo is what makes functional blood
vessels that anastomose with the parent vasculature. VF may be viewed as a product of injury-inducible, TNT-responsive,
adaptive physiological state change aimed at tissue repair. Mechanisms underlying iV caused by TNTEFF remain unknown.
We hypothesize that specific skin fibroblast subset of the dermis enables iV in response to EFF. To test this, we have
developed an inducible transgenic mouse to selectively overexpress EFF in COL1A2-producing dermal fibroblast in acutely
wounded animals (Aim 1). To probe the mechanism of EFF-induced VF generation (Aim 2), we will test the hypothesis that
EFF interacts with ten-eleven translocation (TET) methylcytosine dioxygenase enzymes to demethylate and increase
transcription of endothelial genes in fibroblasts in a manner that permits overcoming of diabetes-induced methylation
barriers. Aim 1. Test the significance of vasculogenic fibroblasts (VFEFF) in tissue repair as a function of targeted delivery
and disease state. 1.1 Dermal fibroblast-specific delivery of EFF in vivo enhances VF generation and improves skin tissue
perfusion and quality of wound healing. 1.2 The diabetic state blunts VF induction and is associated with diminished
perfusion and delayed wound healing that is overcome by delivery of EFF to wound-edge (WE) tissue. Aim 2. Test the
significance of TET enzymes in EFF induced VF state change. 2.1 Diminishing “endothelial gene” promoter methylation in
fibroblasts is required for EFF induced VF formation. 2.2 TET2 activity is essential for demethylating EC signature gene
promoters to induce VF in WE tissue. 2.3 TET deficiency presents a barrier to EFF induced VF state change in diabetic
mice that is overcome with TET and EFF concurrent delivery. This work aims to develop novel bioengineered regenerative
medicine based vasculogenic solutions.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Diabetic wound complications represent a major public health burden. The proposed work seeks to understand and develop a novel technology aimed at reprogramming the wounded skin to generate new blood vessels aimed at improving wound outcomes. The work identifies epigenetic barriers posed by diabetes and seeks to overcome them.